Next-generation SMARTs for Discovery and Evaluation of Sequential Cancer Therapeutic Strategies

Treatment of cancer is an ongoing process during which clinicians make a series of decisions at critical points
in a patient's disease by synthesizing baseline and evolving patient information with the goal of optimizing
expected long-term patient beneﬁt. We use the term “treatment” to refer broadly to therapeutic agents and
supportive behavioral interventions to mitigate adverse effects of therapies or symptoms, as well as to inter-
ventions focused on prevention and screening. An evidence-based approach to optimizing decision making
is to study entire sequential treatment strategies, which can be formalized as treatment regimes. A treatment
regime is a sequence of decision rules, each of which is associated with a key decision and uses accrued
information on a patient to select a treatment option from among the feasible options for the patient. An
optimal regime is one that maximizes expected patient beneﬁt in the population. Sequential multiple assign-
ment randomized trials (SMARTs), in which subjects are randomized at each of several key decision points to
feasible treatment options based on their accrued information, are ideally suited to discovery and evaluation
of treatment regimes, and a number of SMARTs in cancer have been conducted. At the same time, great
innovations have been made in cancer clinical trials; platform and response-adaptive trials that seek to op-
timize treatment for both participants and future patients and that allow for incorporation of new options and
elimination of ineffective options are increasingly being conducted. The potential for SMARTs to advance op-
timal sequential decision making in cancer treatment thus requires a next generation of design and analysis
methods for SMARTs that incorporate similar innovations in the more complex setting of multiple decisions
and repeated randomization of subjects and that address current cancer research priorities. The goal of this
project is to develop a comprehensive statistical framework for next-generation SMARTs in cancer research,
the ﬁrst steps toward which we will undertake through four speciﬁc aims. Our ﬁrst aim is to develop methods for
design and analysis of platform SMARTs that use response-adaptive randomization to favor optimal treatment
assignments and allow introduction of new treatments and discontinuation of ineffective treatments at any de-
cision point. Aim 2 is to develop methods for design and analysis of SMARTs involving multi-component and
multi-modal treatments at each decision point. Our third aim proposes a novel trial framework that merges a
SMART with a micro-randomized trial to allow joint optimization of sequential therapeutic decisions and selec-
tion of supportive mHealth interventions that address the adverse consequences of cancer therapy, where the
supportive interventions are chosen to maximize the success of therapy. In Aim 4, we develop a framework for
interim analysis of SMARTs, for which little methodology is available. The methods handle binary, continuous,
and censored time-to-event outcomes of interest in cancer research. A software package will be developed to
assist users in the design and analysis of next-generation SMARTs.

Public health relevance
Treatment, management, and prevention of cancer involves a series of decisions over time based on accruing patient information. This research will develop methods for the design and analysis of specialized clinical trials that are ideally suited to discovery and evaluation of overall strategies for cancer treatment, management, and prevention over an entire sequence of decisions, with the goal of identifying strategies that lead to the greatest expected patient beneﬁt.